Engineering programmable enzymes for proteome editing

Project Summary/Abstract
The development of CRISPR/Cas9 technology for genome editing and reprogramming was one of the
most important discoveries in the past decade. The ability to deliver instructions to a specific DNA locus enables
systematic interrogation of genetic functions in a broad range of species. In contrast to genomic research, our
ability to manipulate the proteome, the functional components of a cell, lags far behind. Natural protein-modifying
enzymes, such as proteases and kinases, generally lack the exquisite specificity to perform targeted activities
directed to a particular protein. A strategy that enables user-controlled, target-dependent enzyme activation
would enable new opportunities for interrogating, modulating, and harnessing endogenous protein functions.
In this work, we design autoinhibited enzymes that are activated in response to a highly specific antigen-
antibody interaction. These novel enzyme architectures are engineered to have a built-in capability to toggle
between a target-unbound, enzyme-inactive conformation and a target-bound, enzyme-active conformation. We
present a research plan that outlines the development of a target-activated protease, luciferase, and a kinase,
and the subsequent application of the engineered enzymes for controlling protein degradation, constructing
biosensors, and re-writing cell signaling pathways. These synthetic enzymes adopt regulatory mechanisms
entirely different from the endogenous counterparts, enabling wide possibilities for both basic research and
synthetic biological applications.
1

Public health relevance
Project Narrative The ability to label, modify, and manipulate endogenous proteins would enable a wide range of applications in biology and biomedicine. This research plan describes the development of modular molecular architectures for devising programmable enzymes for such purposes. A successful completion of this proposal will establish transformative technologies with exceptional generality, modularity, and flexibility for reprogramming the proteome. 2